A Global Genomic Enhancer Strategy for Repressive Transcriptional Programs

PROJECT SUMMARY ABSTRACT The functional specialization, healthy life, and proper disposal of cells in all metazoans require precise genomic transcriptional responses to developmental and environmental signals. These responses are largely mediated by enhancers, regulatory DNA elements that contain specific recognition sequences required for binding of transcription factors. An ideal model for investigating the actions of enhancers and transcription factors on transcriptional programs is Estrogen receptor (ERα), which is activated by binding of the sex hormone 17β- estradiol (E2) and interacts with ~7000 possible enhancers in the human genome. A major unanswered question, exemplified by the transcriptional programs directed by ERα is how a DNA binding transcription factor, binding to regulatory enhancers, concurrently regulate global programs of gene activation and repression. While the key role of short-range enhancer-promoter interactions in transcriptional regulation is well established, the detailed influence of enhancer:promoter chromosomal architecture on the putative enhancer- dependent regulatory repressive network remains poorly understood. To uncover the links between such chromosomal structure and regulation of gene transcriptional programs, I hypothesize that E2/ERα binds to a massive number of robust, active enhancers, causing recruitment of coactivators but dismissal of Pol II from these enhancers, causing the failure of eRNA transcription and the resultant repression of coding target gene transcription. To investigate this hypothesis systematically, I propose to develop and apply appropriate powerful contemporary global genomic technologies, including 5C, 3D-DSL, Hi-C, GRO-seq, RNA-seq, and ATAC-seq., and the requisite bioinformatic pipelines for analyzing data. By providing critical mechanistic insights into the regulation of transcriptional programs relevant to most organ systems, the proposed research may help to advance the design of new modalities to address questions of development, homeostasis, metabolism, and aging. In so doing, I will not only gain critical scholarship in central global genomic and molecular biological issues, but I also will become proficient in the use of rapidly-emerging advanced bioinformatic and statistical methods for the analysis of large experimental data sets. This NRSA Individual Postdoctoral Fellowship will therefore empower me to acquire invaluable knowledge, training, and experience, while making an important contribution to biomedical science, critical to my goal of becoming a particularly effective independent investigator, dedicated to making transformative discoveries regarding fundamental questions in genomic biology.

Public health relevance
PROJECT NARRATIVE Global genomic approaches permit insights into the regulatory strategies by which enhancers can dictate broad repressive, as well as activating, transcriptional programs. Here, I propose to use the ability of estrogen receptor α (ERα) to repress a large transcriptional program in breast cell line models as an ideal system in which to explore a novel molecular mechanism for large genomic programs of enhancer-dependent transcriptional repression, an important, largely unsolved problem in genomic research. Undertaking this proposal simultaneously represents a critical opportunity to obtain the training in global genomic technologies, gene regulation, cell genetics and new aspects of bioinformatics, all required for achieving my goal of becoming an independent investigator capable of contributing to central questions in gene regulation.